Role of AIOLOS in T Cell Mediated Pathogenesis of Inflammatory Bowel Disease

Project Summary:
Inflammatory bowel disease (IBD) affects 3.1 million people in the United States, yet the precise mechanisms
underlying its pathogenesis remain incompletely understood. Genome-wide association studies have identified
multiple genes linked to IBD, including IKZF3, which encodes the transcriptional repressor AIOLOS, a protein
exclusively expressed in lymphocytes. While these findings suggest a role for AIOLOS in immune regulation, the
exact mechanisms by which it contributes to immune dysregulation in IBD are not fully elucidated. In our
preliminary studies using murine models, we demonstrated that AIOLOS plays a crucial role in restraining the
activation of CD4⁺ and CD8⁺ T cells. Specifically, AIOLOS-deficient mice exhibited heightened T cell activation
and exacerbated disease in a mouse model of immune-mediated colitis. Mechanistically, we found that AIOLOS
regulates T cell responsiveness to interleukins IL-2 and IL-12, which signal through the STAT5 and STAT4
pathways, respectively. These findings highlight the importance of AIOLOS in maintaining immune homeostasis
and preventing excessive inflammation in the gut.
Building upon these findings in mouse models, we aim to investigate whether similar mechanisms operate in
humans and contribute to IBD pathogenesis by analyzing biorepository samples from healthy individuals and
patients with IBD collected and stored at our institute, University of Colorado. We hypothesize that altered
expression or function of AIOLOS in human T cells leads to excessive activation of CD4⁺ and CD8⁺ T cells in
some IBD patients, resulting in chronic intestinal inflammation. In Aim 1, we will investigate the functional role
of AIOLOS in human T cell activation by utilizing CRISPR-Cas9 genome-editing technology to delete AIOLOS in
human T cells. After AIOLOS deletion, we will assess how its absence impacts T cell functions, including cytokine
production and proliferation in response to cytokine stimulation. We will also analyze the transcriptomic changes
resulting from AIOLOS deletion using RNA-seq. In Aim 2, we will compare AIOLOS expression patterns between
healthy individuals and patients with IBD. We will isolate peripheral blood mononuclear cells (PBMCs) from both
groups, stimulate T cells with various cytokines (IL-2, IL-6, IL-12, IFNα), and analyze AIOLOS expression using
flow cytometry. Additionally, we will compare AIOLOS expression in T cells isolated from the inflamed intestinal
tissues of IBD patients to those from healthy control intestines to determine whether its expression is altered in
the local immune environment. By integrating our murine findings with human studies, we aim to create a
comprehensive understanding of AIOLOS's role across species, strengthening the translational potential of our
research. This approach allows us to build on established mechanisms from murine models while assessing
their relevance to human health and disease. Overall, this study will enhance our understanding of AIOLOS’s
role in human T cell biology and its potential contribution to immune dysregulation in IBD.

Public health relevance
Narrative Inflammatory bowel disease (IBD) poses a significant health challenge, with the aberrant function of CD4+ and CD8+ T cells playing a critical role in disease progression. Our research will investigate the impact of AIOLOS, a transcriptional repressor, whose polymorphisms are observed in IBD patients, on human T cell function. This project aims to advance our understanding of IBD pathogenesis and potentially identify novel therapeutic targets.